ROLE OF THYROID HORMONES IN PROTEIN METABOLISM DURING FASTING

To study the effect of changes in thyroid hormone on fasting energy expenditure and protein metabolism in healthy slightly overweight volunteers during a seven to fourteen day fast.